Targeting pathogenic innate lymphoid cells in airway disease

Analysis of 75,770 military personnel from 2001 to 2013 in the Millennium Cohort Study found that up to
5% developed new-onset asthma and combat exposure increased the risk by 24-30%. Specifically, deployment
to Iraq and Afghanistan, which represents the largest cohort of current Veterans (VetPop 2016), significantly
increased the risk of new-onset asthma with an incidence of up to 14%. In recent studies, new onset asthma
was diagnosed in 31-52% of soldiers with post deployment respiratory complaints at the War Related Illness and
Injury Study Center (WRIISC). Deployed Veterans to the Middle East are at increased risk of developing new
onset asthma compared with control non-deployed soldiers and most base-deployed personnel (>85%) have
been exposed to burn pits which are implicated in asthma and other chronic lung diseases. Areas around burn
pits emit elevated levels of fine particulate matter (PM), polyaromatic hydrocarbons (PAH), and dioxins though
limited data exists regarding how these burn pit components may induce aberrant airway immune responses. In
this proposal, we will test how lung innate lymphoid cells (ILCs) promote asthma features in WT C57B/6 mice
after intranasal challenges with combinations of BaP (PAH), TCDD (dioxin), and PM with and without a fungal
allergen present in Middle East dust storms (Alternaria alternata). We will analyze mice for levels of airway
inflammation, mucus production, and airway hyperresponsiveness (by invasive PFT). ILC endpoints assessed
by flow cytometry include intracellular cytokine production, proliferation, and with single-cell RNA-sequencing.
We will test whether ILC activation in the burn pit-relevant model can be suppressed by targeting the intracellular
protein STING and whether STING regulates ILC inhibition through RNA binding protein RBM3. In translational
studies, we will perform in vitro human ILC assays with burn pit-relevant components and assess ILC changes
with STING activation. Finally, we have assembled co-investigator team with Million Veteran Program (MVP)
genomic expertise (Dr. Nievergelt VA San Diego) and propose to assess ILC gene and high-risk asthma SNP
association with Veteran asthma in the MVP database. Given our robust preliminary data, we expect to find that
ILCs promote asthma features in the burn pit model and targeting STING can suppress ILC responses and lung
inflammation, in part through RBM3. We also expect these findings to translate to human ILC responses and
that ILC-related SNPs will link with Veteran asthma.

Public health relevance
New-onset asthma prevalence is up to 14% of previously healthy military personnel deployed to the Middle East that now make up most Veterans. A significant number of previously deployed Veterans have been exposed to burn pits which emit many irritant and toxic compounds including dioxins, aromatic hydrocarbons, and particulate matter. We have developed a novel pre-clinical model in which mice are exposed via the airway to a combination of these substances along with a fungal allergen also present in dust storms. We propose to identify how immune cells, “ILCs”, promote lung inflammation in this model and we will test a novel treatment strategy to inhibit these cells. We will also use the Million Veteran Program database to identify ILC-related risk genes for asthma in the Veteran population. Our overall goals are to better understand mechanisms and discover therapeutic targets for Veteran asthma.